CTCF dependent chromatin looping dynamics

Enter the text here that is the new abstract information for your application. The organization of the nucleus and the regulated folding of the genome plays essential roles in regulating gene expression, chromosome segregation and chromosome structure. Long range interactions in chromatin are required for activation of gene transcription and repression of genes during the differentiation of eukaryotic cells. Long-range contacts between different chromosomal loci also regulate processes such as antibody diversity and mitotic chromosome condensation. Despite the wide range of processes that involve chromatin loops we know very little about the mechanisms that drive chromatin folding and stabilize long range interactions in the genome. This proposal is focused on developing new methods to measure the formation of looped domains dependent upon the activity of the chromatin protein CTCF. CTCF is known to be required for the stabilization of looped regions in the genome but how it generates or stabilizes looped domains is unknown. We propose to first characterize the dynamics of CTCF dependent looping using defined chromatin substrates in vitro and on chromatinized plasmids in cell extracts. Using mutagenesis and depletion we will alter the binding affinity and dimerization properties of CTCF and its interaction with the loop stabilizing protein cohesin to determine how these activities regulate the frequency of loop generation. Using the insight we gain from these in vitro experiments we will compare the dynamics of loop formation to the statistics of long range interactions at the human globin locus. By depleting CTCF and cohesin we will relate the cellular statistics of loop formation to the in vitro mechanics of loop stabilization. Our studies should provide unique and novel insight into the processes that regulate the formation of long range chromatin interactions and how they relate to essential developmental and cell biological processes.

Public health relevance
public health relevance information for your application. No modifications __SpecificAimsTextDelimiter__ Enter the text here that is the new specific aims information for your application. Numerous processes in eukaryotic nuclei depend upon interactions between chromosomal loci that are distant from one another along the length of the chromosome. Transcriptional activation by enhancer promoter contact, immunoglobulin locus recombination and the regulation of parentally imprinted loci involve chromosomal looping interactions that juxtapose sequences that are separated by 10s to 100s of kilobases of DNA. The zinc-finger protein CTCF has been assigned a wide range of roles in nuclear organization, with CTCF-dependent chromatin looping featuring prominently among its suggested mechanisms of action. Precisely how CTCF establishes and maintains chromatin loops and bridges is not yet clear, however, and very little is known about the dynamics of these processes. It is known that CTCF itself can dimerize, suggesting a straightforward model for the mechanism by which CTCF bridges and loops chromatin. It has been suggested that the conformation and thus the binding/dimerization affinities of chromatin-bound CTCF may depend on details of the underlying target sequence, giving rise to a "CTCF code" model for the site-specific modulation of CTCF activity by DNA. However it has also been observed in several contexts that cohesin is essential for maintaining CTCF-mediated chromatin conformation, suggesting alternative models in which CTCF might not be able to loop chromatin on its own. Our goal is to understand the mechanisms of CTCF dependent chromosome loop stabilization and how CTCF is influenced by other chromosome regulatory factors to regulate the behavior and dynamics of different chromosomal loci. Specific Aim 1 - Mechanisms and dynamics of CTCF-dependent chromatin looping To probe the dynamics and mechanisms of CTCF dependent chromatin looping we will characterize CTCF binding to specific DNA target sequences embedded in defined chromatin contexts, as well as the dimerization of CTCF binding sites to relevant partner proteins in vitro. We will also characterize the statistics of CTCF-dependent looping on chromatin fragments in Revised Specific Aims Aaron F. Straight and Hideo Mabuchi 1 R01 GM106005 vitro. We will elucidate the potential roles of histone composition, DNA methylation and cohesin association on the dynamics of CTCF-dependent chromatin looping by manipulating the composition of chromatin in vitro and using cell extracts. Our experimental approach will utilize a novel single-molecule fluorescence technique, tracking-Fluorescence Correlation Spectroscopy, that enables the measurement of chromosome looping dynamics on individual chromatin domains. Specific Aim 2 - Regulation of CTCF dependent chromosomal looping in human cells CTCF is required for regulating the developmental expression pattern of the globin genes by mediating chromatin loop formation at the globin gene cluster in vertebrates. Loop formation at the globin locus requires binding of CTCF with to specific DNA sites in the globin locus regulatory regions. Loop formation by CTCF is modulated by both DNA methylation of the CTCF binding sites and cohesion association with the globin locus. To understand the relative contributions of chromatin loop regulators to the dynamics of chromatin loop formation in cells we will measure the single cell distribution and statistics of loop formation after manipulation of CTCF DNA binding, homodimerization and cohesin association. We will use these cellular measurements to test the predictions that arise from our in vitro experiments regarding proximity statistics for sites within the globin locus in vivo